Perioperative Telemonitoring to Optimize Cancer Care and Outcomes

PROJECT SUMMARY
The overall purpose of this proposal is to conduct a pilot randomized trial of a remote perioperative
telemonitoring intervention to improve patient-centered outcomes, surgical outcomes and healthcare resource
use in English and Spanish-speaking patients scheduled to undergo major abdominal gastrointestinal cancer
surgery. This research is critical because after cancer surgery, patients experience abrupt declines in
functional capacity, increase in symptoms and an overall dramatic decline in quality of life with the majority of
postoperative care and recovery taking place at home. While at home, physical function can decline prior to the
surgical team being notified leading up to one third of patients becoming symptomatic from a complication that
may require readmission. Telemonitoring of symptoms in the perioperative period including vital signs, weight,
steps taken and patient reported outcomes allows for an opportunity to intervene in the perioperative period to
mitigate severity of complications and readmissions. The intervention is perioperative measurement of
parameters in both groups with a nursing triage as the intervention to intercept complications and to improve
patient reported outcomes. We will pilot test the intervention using a 1:1 randomization to pursue the following
specific aims: Specific Aim 1: Assess the feasibility, retention, and acceptability of the remote perioperative
telemonitoring intervention as measured by the percentage of patients who a) agree to participate; b) complete
>70% of the telemonitoring; and c) report satisfaction with the intervention through structured exit interviews;
Specific Aim 2: Determine the preliminary efficacy of the remote perioperative telemonitoring intervention on
surgical outcomes, healthcare utilization, PROs, and functional recovery. This proposal is innovative because
we are among the first and few to study methods of transforming patient-centered outcomes into actionable
postoperative cancer care using objective and subjective measures in addition to using an existing digital
health infrastructure (AetonixTM) leveraging a “real world” platform for expansion into surgical oncology. The
interdisciplinary team which includes expertise in surgical oncology (Melstrom) and nursing science (Sun) is
uniquely suited to conduct this research. The proposal is significant, with high scientific rigor and outcomes
that are of critical importance in perioperative care to cancer patients, clinicians, healthcare systems and the
National Cancer Institute. This research will address a critical gap in knowledge of how perioperative
telemonitoring of objective and subjective data will improve outcomes and transitions of perioperative cancer
care outside of the hospital setting. Our long-term objective is to conduct a multi-site, Phase III trial of the
intervention to establish effectiveness.

Public health relevance
Project Narrative The overall purpose of this R21 grant application entitled “Perioperative Telemonitoring to Optimize Cancer Care and Outcomes” is to conduct a pilot randomized trial of a remote, perioperative telemonitoring intervention to improve patient-centered outcomes, surgical outcomes, and healthcare resource use in patients scheduled to undergo major abdominal gastrointestinal cancer surgery. In collaboration with the Beckman Research Institute of City of Hope and AetonixTM systems, we have a unique opportunity to assess the feasibility, retention and acceptability of a remote telemonitoring intervention. Completion of the study will improve our understanding of the efficacy of a remote telemonitoring intervention on surgical outcomes, healthcare utilization, patient reported outcomes and functional recovery.